Dissecting the role of mirtrons in human cancers

Project Summary/Abstract
Mirtrons are a new class of small RNAs. Previous findings show mirtrons are generated by splicing and
are less stable than canonical miRNAs. Thus, the expression of mirtrons is often negligible. Additionally, most
mirtrons exhibit distinct evolutionary properties relative to solo and mammals have way more mirtrons than lower
organisms suggesting some unknown importance of mirtrons in mammals. Recently, elevation of mirtrons has
been linked to human cancers and immune disorders. However, the biological significance of mirtrons in humans
is not well understood due to very limited efforts of mirtron research in humans. It is therefore important to
investigate how biogenesis of mirtrons is stabilized during disease development and how increased mirtron
expression promotes tumor/disease progression.
In ongoing experiments, we show most mirtrons elevated in human cancers contain guanine rich
sequence that forms G-quadruplex, a secondary structure that has been implicated as a strategy adopted by
some RNA viruses to evade the host exoribonucleases, XRN1/2 mediated digestion. We also show XRN/1/2 are
crucial enzymes for mirtron stability that mirtrons in cancer cells significantly increase when XRN1/2 are knocked
down. Additionally, all cancer mirtrons are featured with many (long) terminal nucleotide additions which result
in abundance of mirtrons present in the cancer derived exosomes. Furthermore, we also show mirtrons from the
cancer derived exosomes bind to the endosomal Toll-like receptor 7 (TLR7) of macrophages suggesting mirtrons
are novel ligands of TLR7 and potentially modulate immune responses.
Given these findings, we hypothesize that cancer cells selectively express mirtrons exhibiting high
guanine contents that could form G-quadruplex structure to bypass XRN1/2 mediated degradation. The
nucleotide addition to the 3’ tail provides preferential sorting of mirtrons into exosomes. Cancer exosomes can
be taken by immune cells through endocytosis providing the opportunity for mirtrons to bind to TLR7. The binding
of mirtron to TLR7 serves as an allosteric inhibitor to block TLR7 signaling and the associated downstream
immunological responses. These hypotheses will be addressed in the experiments of the following Specific Aims:
(1) to determine the impact of G-quadruplex structure of mirtrons on the resistance to exoribonucleases, XRN1/2;
(2) to determine the consequence of altered mirtron precursor tailing on exosomal sorting; and (3) to evaluate
the immune modulatory role of cancer mirtrons through binding to TLR7. Should this exploratory study reveal
novel mechanisms of cancer mirtron stabilization and sorting into exosomes, and should these cancer mirtrons
negatively regulate the TLR7 signaling and the related immune functions, novel therapeutics aimed to destabilize
mirtron, to prevent their sorting into exosomes, and/or to compete mirtron binding to TLR7 may provide benefits
to cancer treatment in addition to advance current knowledge of mirtrons in humans.

Public health relevance
Project Narrative In this study, we propose to investigate the biogenesis of mirtrons in cancers and to examine the potential roles of mirtrons in the modulation of tumor immune responses. Mirtron is an emerging new RNA subclass in the field but its biological importance in humans is completely not understood. Thus, successful completion of the project will advance current knowledge of mirtrons and their involvement in the immune regulation that will inform therapeutic strategies to treat cancers.